HORMONAL REGULATION OF CELLULAR METABOLISM

This project focuses on the functions of protein kinases and protein phosphatases in transducing extracellular signals initiated by hormones, neurotransmitters, growth factors, and antigens. Covalent modification of proteins by phosphorylation/dephosphorylation plays a central role in mediating many cellular events resulting from ligand-receptor interaction and generation of a variety of second messengers. Several protein kinases, especially the Ca2+/phospholipid/diacylglycerol- stimulated protein kinase C family, and phosphatases have been prepared from rat brain for the identification of protein substrates modified by these enzymes. Several novel proteins have been isolated by ion-exchange and reverse phase chromatography and their partial amino acid sequences determined. The effects of phospholipids and Ca2+-binding proteins, calmodulin, and S-100 protein on the phosphorylation/dephosphorylation of these proteins are being investigated. In addition, modification of the protein kinase C substrate, neurogranin, by oxidizing agents such as hydrogen peroxide and nitric oxide has been shown to influence the kinase-catalyzed phosphorylation. Molecular cloning of the cDNAs of these novel protein kinase C substrates is in progress. The genomic structures of the CNS-specific protein kinase ~ isozyme and its substrate, neurogranin, have been elucidated. The mechanisms controlling the tissue-specific and developmental stage-regulated expression of these two genes are currently being investigated.